Diversity Supplement: Understanding mucus composition and function in asthma

PROJECT SUMMARY
As asthma worsens, occlusion of airways with mucus significantly contributes to airflow obstruction. Recent
evidence has suggested mucus obtained from individuals with severe asthma possesses altered mucin
composition. However, how these changes alter the functional properties of the mucus gel is not yet fully
understood. The overall objectives in this application are to (i) establish new models where mucus composition
can be precisely controlled for mechanistic assessment of its function and (ii) understand the role of mucus
composition in viral infection-induced exacerbation of disease. The central hypothesis is airway mucus with an
imbalanced concentration of the 2 primary gel-forming airway mucins, MUC5B and MUC5AC, possesses
significantly altered biophysical properties that leads to impaired function in asthma. The central hypothesis
will be tested through development of two new model systems: a bioengineered hydrogel that mimics native
mucus and a genetically engineered human lung tissue culture model capable of producing mucus with a
composition representative of healthy and asthmatic airways. In comparison to the standard models used, the
primary advantage of our model systems is the capability to systematically vary the composition of mucus to
capture how these changes might impact its physiological function. Our approach will enable for a mechanistic
understanding of conditions under which the mucus gel becomes immobile, thus reduces its ability to be
effectively cleared and increases the likelihood for mucus plug formation in the lungs of individuals with
asthma. In addition, the impact of composition on the barrier function of mucus towards influenza virus will be
examined using these state-of-the art model systems and a transgenic mouse model of severe asthma. The
research proposed in this application is innovative as it employs tools from molecular biology, biophysics, and
engineering to develop a novel means to control and assess mucus composition by closely mimicking its
properties in healthy and asthmatic airways. If successful, the results of this work will be significant as our
approach may provide new insights into the biological function of mucus in asthma, also with relevance to other
related muco-obstructive lung diseases.

Public health relevance
PROJECT NARRATIVE Asthma is a chronic lung disease affecting millions worldwide. We currently have a limited understanding of how the changes to mucus observed in disease contribute to its function. The proposed research aims to provide a new, highly valuable means to understand the impact of disease-associated changes in mucus composition to lung airway dysfunction in asthma and other related muco-obstructive lung diseases.